GH AND PROLACTIN PROFILES IN ACROMEGALY DURING SANDOSTATIN THERAPY

This study is intended to determine the effect of the somatostatin analogue,Sandostatin, on growth hormone and prolactin secretion in patients with acromegaly.